Institutional Career Development Core

Contact PD/PI: Disis, Mary L. Inst-Career-Dev-001 (378)
Given the complex challenges of developing preventative measures and novel treatments for disease and
improving health, we see an imperative to train the next generation of translational researchers in an
interdisciplinary environment. The Institute of Translational Health Sciences (ITHS)—a partnership between the
University of Washington, Seattle Children's, and Fred Hutchinson Cancer Research Center—is an incredibly
rich environment for clinical and translational research and attracts PhD, MD and other clinically trained
investigators. The reach of ITHS extends beyond its hub in Seattle across Washington, Wyoming, Alaska,
Montana, and Idaho (WWAMI), providing distinct opportunities, particularly in the areas of rural health and
underserved populations, through clinical research networks and collaborating universities. Since 2007, the ITHS
KL2 Multidisciplinary Career Development Program has cultivated a group of talented junior faculty from a wide
variety of disciplines. The primary goal of the 3-year program is to prepare a diverse group of early career faculty
to lead interdisciplinary teams conducting translational research that will ultimately improve human health. ITHS
provides salary and research funds, protected time, and mentorship to 9 scholars each year. The 62 scholars
trained to date produced 458 publications while in the program and have been awarded more than $73M in NIH
funding. ITHS now proposes to enhance the existing KL2 program through two new major aims to:
1. Create a larger, more inclusive cohort to promote scholar engagement through the addition of an
institutionally supported KL2 seminar fellows program. We will maintain 13-15 seminar fellows per year,
early career investigators who participate fully in the KL2 curriculum for up to 2 years but are supported by
other funds. The larger cohort will enrich the KL2 experience for funded scholars by providing more
opportunities for peer engagement and adding more diverse research perspectives, as well as those from
different cultural and social backgrounds, which have a positive impact on innovation.
2. Increase the diversity of the KL2 cohort to support more scientists from underrepresented
backgrounds on the basis of race/ethnicity, disability, and social disadvantage, and from regional
research organizations. We will expand outreach, purposeful recruitment, and pre-application support to
draw more investigators from outside the 3 Seattle-based partners and investigators from groups identified
by NIH as underrepresented in biomedical, clinical, behavioral, and social sciences. Centering this as a major
aim will help us create a more diverse translational research workforce.
KL2 scholars and seminar fellows will be rigorously trained using a curriculum grounded in translational science
core competencies in a unique interdisciplinary environment. Scholars benefit from guidance of their scientific
mentors and KL2 Program Directors. Graduates will be positioned to lead effective research teams that work
across disciplinary boundaries, making a positive impact on human health, and reaching a range of communities.